Elucidating the Mechanisms by which Macrophages and their TAM Receptors Promote Cardiac Regeneration

Project Summary
The prevalence of post-myocardial infarction (MI) heart failure is increasing across the United States, since
current therapeutic strategies fail to regenerate the injured myocardium. While other organ systems exhibit the
ability to regenerate after tissue injury, the adult human heart lacks this crucial capability. With the discoveries
of multipotent cells and advanced culturing and differentiation techniques, studies have focused on stem cell-
based therapeutic approaches to replenish depleted cardiomyocytes. Clinical trials, however, have yet to register
a significant impact of these therapies on cardiac function, thus necessitating novel and creative approaches to
regenerate the injured myocardium.
Remarkably, innate immune cells are required for both cardiac development and regeneration. Ablation of
neonatal cardiac macrophages (MΦs) impairs the regenerative response, inhibiting the remuscularization and
revascularization of the myocardium. The precise molecular mechanisms, however, for the regenerative
reprogramming of macrophages remain unknown. Therefore, the long-term objective of this proposal is to identify
the underlying cellular and molecular mechanisms by which neonatal macrophages coordinate mammalian
cardiac regeneration.
Among the many molecules that influence MΦ function, the TAM (Tyro3, Axl, MerTK) family of tyrosine kinase
receptors are emerging as exciting therapeutic targets for heart disease. This proposal hypothesizes that
MerTK is required to program distinct neonatal cardiac MΦs to secrete pro-regenerative mediators that
coordinate cardiac regeneration. This hypothesis will be interrogated using genetic manipulation of MerTK in
neonatal mice after myocardial infarction. Heart regeneration will be determined by the degree of fibrosis, the
induction of cardiomyocyte proliferation, and the recovery of cardiac function as seen by echocardiography.
Additionally, single-cell transcriptomics of cardiac MΦs before and after cardiac injury will unveil the MerTK-
dependent mechanisms neonatal cardiac MΦs utilize to coordinate regeneration. These mechanisms of cardiac
regeneration will be validated to confirm the regenerative functions of neonatal MΦs.
Dr. Edward Thorp’s laboratory and Northwestern University provide both the expertise, facilities and necessary
equipment required to thoroughly interrogate the aims of the proposal. Overall, the proposed study will have
broad implications for how innate immune cells and their receptors directly execute regenerative functions. These
findings may identify novel therapeutic strategies to induce cardiac regeneration in humans, alleviating the
burden of post-MI heart failure on public health.

Public health relevance
Project Narrative Despite the prevalence of post-myocardial infarction heart failure, existing therapies are ineffective of regenerating the injured myocardium demonstrating the need for novel therapeutic strategies to promote regeneration. The proposed study aims to understand how the macrophage tyrosine receptor MerTK drives cardiac regeneration. Specifically, this project seeks to uncover MerTK-dependent macrophage reprogramming responsible for the secretion of pro-regenerative mediators such as Thromboxane B2 that promote cardiac regeneration.